A Novel, AI-Enabled Dementia Care Agent to Reduce Disparities for Rural ADRD Care Partners.

PROJECT SUMMARY
Care partners of individuals with Alzheimer’s Disease and Related Dementia (ADRD) in rural areas experience
higher caregiving burden and lower social support compared to urban caregivers. Although caregiver
education and support delivered by home and community-based service (HCBS) providers has demonstrated
the ability to reduce caregiver burden, those serving rural areas often face workforce shortages and capacity
constraints, limiting their service availability and accessibility among rural care partners. Further, no scalable
intervention currently exists to enable HCBS providers to deliver real-time education and support tailored to the
evolving needs of rural ADRD care partners.
To address these critical gaps, we plan to develop the AI-enabled Dementia Care Agent that will be available
as a 24x7 service to support rural ADRD care partners. The Dementia Care Agent, which will be provided to care
partners through HCBS providers, will utilize vetted ADRD caregiving education and support content from
National Institute on Aging, AGEucate, and other authoritative sources. This specialized knowledge base will be
added to a large language model (LLM), a machine learning system that can generate and understand complex
human language interactions. We will integrate the Dementia Care Agent with CareVirtue’s proven caregiver
support platform to provide tailored ADRD education and support while enhancing the ability of rural HCBS
providers to increase capacity to provide ADRD education and support. Our goal is to provide a personalized,
context-aware Dementia Care Agent that is accessible to rural ADRD care partners for real-time support needs
and alleviate the ADRD education and support capacity limitations faced by many HCBS providers.
Our multi-disciplinary team includes experts in machine learning, AI agents, LLM technology, software
commercialization, ADRD caregiving support, and HCBS providers serving rural ADRD care partners. Our long-
term objective is to commercialize the Dementia Care Agent intervention to provide real-time support to rural
ADRD care partners, increase the availability and accessibility of ADRD education, improve capacity for
HCBS providers, and reduce the disproportionate burden that rural ADRD care partners face by overcoming
barriers to availability and accessibility for needed ADRD education, training, and support.

Public health relevance
PROJECT NARRATIVE Care partners of individuals with Alzheimer’s Disease and Related Dementia (ADRD) in rural areas experience higher caregiving burden and lower social support compared to urban caregivers. Although caregiver education and support delivered by home and community-based service (HCBS) providers has demonstrated the ability to reduce caregiver burden, those serving rural areas often face workforce shortages and capacity constraints, limiting their service availability and accessibility among rural care partners. Further, no scalable intervention currently exists to enable HCBS providers to deliver real-time education and support tailored to the evolving needs of rural ADRD care partners. In this proposed Fast Track, we will develop the AI-enabled Dementia Care Agent that will be available as a 24x7 service to support rural ADRD care partners and enhance the service capacity and accessibility among rural HCBS providers. The Dementia Care Agent machine learning system will leverage a specialized knowledge base, built from vetted, authoritative ADRD caregiving education and support content. Integrated with CareVirtue’s proven caregiver support platform, it will deliver personalized ADRD education and support while empowering rural HCBS providers to expand their capacity to support care partners effectively.